Functional and behavioral dissection of higher order thalamocortical circuits in schizophrenia.

ABSTRACT
Project 5 (P5) will address Center Aim 2 by characterizing mediodorsal (MD) nucleus and pulvinar (PUL) circuit
dysfunction in schizophrenia across levels of analysis, including functional connectivity with cortex, localized
activation during cognition, and behavior. The structure, connectivity, and function of the thalamus are abnormal
in schizophrenia. Thalamic abnormalities are especially pronounced in the MD nucleus and PUL. How MD and
PUL dysfunction contributes to the symptoms and associated features of schizophrenia is largely unknown
posing a significant challenge to developing effective interventions. One of the motivating factors of this Center
application is that the MD and PUL are not only causally involved in cognition, but anatomically and functionally
heterogenous. Consequently, dissecting higher-order thalamocortical circuits across levels of analysis is
essential for understanding the functional consequences of thalamic dysfunction in schizophrenia and identifying
targets for intervention. Working synergistically with P4 resting-state fMRI studies in healthy individuals and
supporting by Core C, Aim 1 will use innovative methods to test the hypothesis that functional connectivity of
MD and PUL subdivisions is abnormal in schizophrenia and further determine if the alterations are diffuse, or
isolated to specific MD and PUL subdivisions. Informed by basic neuroscience discoveries motivating P1 and
P2, Aim 2 will characterize dorsal and ventral pulvinar circuits during attention in schizophrenia. Deficits in
attention are ubiquitous in schizophrenia and may serve as a viable biomarker. We hypothesize that such deficits
may be caused by aberrant engagement of the PUL in regulating information flow across the dorsal and ventral
visual streams. We will test this hypothesis by acquiring simultaneous brain (fMRI) and behavior measurements
in patients and healthy individuals. Aim 3 will use a variant of the Center’s Hierarchical Decision Making (HDM)
paradigm to investigate MD-PFC pathways for regulating cortical excitation/inhibition. Animal models developed
by P3 indicate that resolving sensory uncertainty during decision making depends on different MD-PFC pathways:
one for suppressing noise (conflict) by increasing cortical inhibition, the other for enhancing signal (sparseness)
by decreasing inhibition. Building on preliminary behavioral data with leaders of P3 implicating impaired decision
making under sensory conflict, we will determine if schizophrenia is associated with impaired decision making
under uncertainty when task cues are sparse (low signal), conflicting (high noise), or both. Furthermore, we will
test the hypothesis that MD dysfunction is associated with impaired attentional control under uncertainty in
schizophrenia and determine whether MD dysfunction is more prominent in sparseness- or conflict-based
uncertainty. Core B will provide critical support for modelling behavioral data (Aims 2, 3) to allow cross-species
comparisons. The overall outcomes of P5 will provide the foundation for developing interventions for correcting
thalamocortical dysfunction and cognitive impairment in schizophrenia.